Lipid-Loaded Macrophages in Atherosclerotic Plaque Inflammation

Project Summary
Cardiovascular disease (CVD) has remained the leading cause of death in the United States for over a century.
Underlying CVD is atherosclerosis, a pathogenic lipid-driven and chronic inflammatory response. Lipid buildup
leads to plaque formation and artery stenosis, presenting clinically as myocardial infarction, cerebrovascular
disease, peripheral arterial disease, and aortic aneurysm. In preliminary studies, we show through an integrated
atheroma-derived single-cell RNA sequencing (scRNA-seq) analysis that immune cells, most of which are T cells
and macrophages (Mφ), dominate the atherosclerotic milieu. Further analysis revealed five distinct Mφ
subpopulations, including one showing upregulation of lipid-associated genes. Examination of this lipid-
associated Mφ (LAM) demonstrated marked upregulation of bioenergetic processes. However, specialization of
metabolic processing and lipid clearance came at the expense of core Mφ functions such as antigen presentation
and cytokine production. Comparing LAMs to in vitro lipid-loaded Mφ confirmed that lipid feeding polarized Mφ
towards the LAM phenotype. Epidemiologic data indicated that high LAM scores in the carotid atheroma placed
patients at higher risk for future ischemic events, suggesting that LAMs play a pro-inflammatory and tissue-
destructive role. Assessment of in vitro lipid-loaded Mφ revealed that lipid challenge increased production of
extracellular adenosine triphosphate (eATP), a pro-inflammatory metabolite. Based on these data, we
hypothesize that LAMs, under lipid-dependent metabolic overload, release ATP into the tissue
microenvironment and utilize this metabolite as a signaling molecule to regulate surrounding Mφ. In
pursuit of this hypothesis, we will execute the following aims. In Aim 1, we will characterize the effects of lipid
loading on the metabolic landscape and cell fate decisions of atheroma-derived macrophages. Employing an in
vitro human Mφ model, we will identify CVD-specific Mφ population enrichment, lipid-induced trajectory shifts,
and gene regulatory networks with paired single-nucleus RNA-seq and scATAC-seq multi-omic analysis. We will
also assess for lipid-induced bioenergetic perturbations at the bulk and single-cell level. In parallel, we will
execute comprehensive analyses (e.g. phagocytosis, antigen presentation) to create a LAM functional atlas. In
Aim 2, we will investigate how LAMs exacerbate plaque inflammation by controlling the function of neighboring
macrophage subpopulations. Here, we will lipid load Mφ, assess for steady-state eATP production, and
determine efflux kinetics. We will also develop a comprehensive understanding of how eATP affects atheroma-
derived Mφ subsets by assessing for differential eATP-induced responses (e.g. inflammasome activation) in
faithfully reproduced in vitro Mφ. To identify disease-specific responses, we will perform assays with CVD patient-
and healthy control-derived Mφ. Ultimately, results from this proposal will clarify the link between dyslipidemia
and atherosclerotic inflammation, allowing for novel diagnostic approaches and targeted CVD therapies.

Public health relevance
Project Narrative Cardiovascular disease is a major cause of mortality and disability worldwide, and despite the benefit of lipid- lowering therapies, a large residual burden remains. This project investigates the effect of lipid loading on macrophages and their subsequent influence on surrounding macrophage subpopulations in the atheroma. Results from this study will provide mechanistic insights underlying dyslipidemia and atherosclerotic inflammation, providing opportunities for novel diagnostic and therapeutic approaches.